SYNTHESIZE &CHARACTERIZE DISCRETE OLIGO (DISOLANYLENE ETHYNE 1 ENE) DERIVATIVES

Use of transition metal catalysts to prepare well defined oliigomer sequences. We typically target electroactive sequences.